Novel mechanism controlling calcium signaling to treat and prevent neurodegeneration in early stage glaucoma

Project Summary/Abstract
The proposal is in response to NEI's strategic plan, described recently by NEI in “Vision Research:
Needs, Gaps, and Opportunities”, and focuses on our most recent discoveries of a novel neuronal
mechanism rooted at the intersection of aging and the biological mechanisms of eye disease identified
as a high programmatic priority. The proposed research targets a novel mechanism of neuroprotection
utilizing intracellular calcium channels as drug targets to treat neurodegeneration in glaucoma.
Specifically, we plan to determine mechanisms of action and to measure preservation of neuronal
viability and function in model systems of glaucoma. The proposed research will allow us to generate
preclinical data needed for the development of novel neuroprotectants to complement existing therapies
targeting intraocular pressure: The intracellular free Ca2+ concentration of retinal ganglion cells like in
other neurons of the CNS is highly regulated and subject to dysregulation during aging. For the
development of acute and chronic degenerative diseases including glaucoma reducing the viability and
function of retinal ganglion cells (RGCs) several studies indicate that both changes in intracellular second
messenger concentration and pathological increases in the intracellular Ca2+ concentration promote
pathogenesis. The present application will test the hypothesis that Ca2+ signaling of RGCs is functionally
regulated by an immediate early gene product upregulated in RGCs after a neurodegenerative insult to
generate a cellular defense mechanism. This hypothesis is based on strong preliminary evidence that
normal aging of the retina is mechanistically similar to glaucoma disease processes and can be exploited
to devise novel treatments for glaucoma. The proposed experiments designed to test this hypothesis will
investigate the molecular, cellular and functional mechanisms underlying this interaction under
experimentally induced disease conditions in models of glaucoma. The overall goal of the proposed
study is to identify a novel mechanism of RGC neuroprotection and determine its potential as a strategy
for neuroprotective therapies targeting RGCs. This therapy approach will have the potential to be both
preventative and therapeutic in nature and to complement existing treatment designs and rationales.

Public health relevance
Project Narrative Degeneration or acute damage of nerve cells in the retina as seen in glaucoma is a major cause of visual loss and blindness in the United States and worldwide. As these diseases affect significant and increasing portions of the U.S. population including minorities affected by disparities in health care delivery, determining causes, mechanisms of action and subsequently potential treatment strategies will contribute to improving health care, health and performance requiring visual tasks. The present application uses a novel mechanism underlying a self-defense mechanism of the retina to develop such new treatment strategies and is in response to the NEI's strategic plan, described recently by NEI in “Vision Research: Needs, Gaps, and Opportunities”.